Effect of Time-Restricted Feeding on 24-hour Glycemic Control, Blood Pressure, and Cardiovascular Disease Risk Factors in Adults with Prediabetes

PROJECT SUMMARY
Increasing evidence suggests that while poor meal timing can cause cardiometabolic disease, optimized meal
timing may reverse it. Time-restricted feeding (TRF) is a novel type of intermittent fasting that involves eating
within a ≤10-hour period, followed by a ≥14 hour daily fast. Studies in rodents report that TRF improves glycemic
control, lowers insulin levels, reduces hepatic fat, prevents hyperlipidemia, reduces infarct volume after stroke,
and improves inflammatory markers, relative to eating throughout the day. Importantly, the effects of TRF may
depend on the circadian timing of food intake. Previous TRF trials in humans that limited food intake to the middle
of the daytime (mid-day TRF) reported positive results, while trials that limited food intake to late in the day
reported null or negative results. Building on these studies, we recently conducted the first clinical trial of TRF
where food intake is limited to early during the daytime (early TRF) and found that five weeks of early TRF
improved insulin sensitivity, β-cell responsiveness, blood pressure, and oxidative stress in prediabetic men—
even though food intake was matched to the control arm and no weight loss occurred. Here, we propose to
conduct both (1) the first full-scale trial of TRF in humans and (2) the first trial to determine whether the effects
of TRF depend on the circadian timing of food intake. Our proposed study is a three-parallel-arm, controlled
feeding trial designed to determine the efficacy of TRF as a therapy to improve cardiometabolic health in
prediabetic adults. N=144 prediabetic adults (BMIs 25-50 kg/m2; aged 18-75 years old) will be randomized to
one of three isocaloric eating schedules: (1) early TRF: 6-hour feeding interval from 8 am-2 pm; (2) mid-day
TRF: 6-hour feeding interval from 2 pm-8 pm; and (3) control schedule: 12-hour eating interval from 8 am-8 pm.
For 10 weeks, participants will eat calorie-matched meals under remote supervision by video monitoring, and
food intake will be precisely matched on a meal-by-meal basis to the control group to ensure that no weight loss
occurs. The study endpoints will be measured during a 24-hour inpatient test period at both baseline and post-
intervention. The primary endpoint is 24-hour glycemic control as measured by 24-hour mean values of glucose
and insulin; this data will be complemented by mechanistic data on insulin sensitivity and secretion, as measured
by three identical meal tolerance tests on the same day. The secondary endpoints are cardiovascular disease
risk factors, as measured by 24-hour blood pressure and fasting levels of lipids and inflammatory and oxidative
stress markers. We hypothesize that both TRF schedules will improve cardiometabolic health, but the effects of
TRF will depend on the circadian timing of food intake, with the order of improvements being early TRF > mid-
day TRF > control. This study will provide critical insight into (1) whether TRF can be used to treat metabolic
disease; (2) the relative importance of the length of the daily fasting period (intermittent fasting) versus the
circadian timing of food intake (meal timing) for metabolic health; and (3) whether breakfast skipping (tantamount
to mid-day TRF) is beneficial or detrimental for metabolic health when dinner time is unchanged.

Public health relevance
PROJECT NARRATIVE Time-restricted feeding is a form of intermittent fasting that involves eating within a ≤10-hour daily period, followed by a daily ≥14-hour fast, and which significantly improves health in rodents. In this clinical trial, we will test whether time-restricted feeding improves blood sugar control and cardiovascular disease risk factors in adults with prediabetes. We will also determine whether the benefits of time-restricted feeding depend on the time of day that people eat.